Administrative Core

PROJECT SUMMARY/ ABSTRACT:
COVID-19 exemplifies the dire consequences of being unprepared for the next health crisis. One looming crisis
involves the insidious rise of antibiotic resistant bacterial infections, necessitating the research described in our
U19 application entitled “Innovative strategies to combat antibiotic-resistant infections” in response to
RFA-AI-20-001 (Combating Antibiotic-resistant Bacteria Interdisciplinary Research Units (CARBIRU)).
Our proposal is leveraged to translate basic science into new types of antibiotic-sparing medicines for common
infections in the United States as well as common hospital-acquired infections. This U19 application utilizes a
multi-departmental, multi-institutional, and interdisciplinary group of highly motivated microbiology, cell
biology/physiology, immunology and medicinal chemistry researchers to develop antibiotic-sparing
therapeutics and compounds that are capable of: i) treating common infections; and/or ii) increasing sensitivity
to the current arsenal of available antibiotics. The Administrative Core (AC) will be responsible for coordinating
the activities and monitoring the progress of the three research projects and the two scientific cores to achieve
the overall goals of the U19 program. To accomplish this, the AC Leader, with the help of an Executive
Committee comprising of the Leaders of the Research Projects and Cores, will oversee and coordinate the
activities of the members of the Projects and Cores by: i) fostering frequent interactions; ii) supporting the
exchange of data, methodologies, and ideas; iii) facilitating interactions with institutional and outside experts to
gain advice for better functioning of the overall program and for translation of the program's findings into
therapeutics development; and iv) coordinating financial and scientific progress reporting to granting agency
staff. In addition, the AC will coordinate active participation in the U19 to ensure its overall success.